Investigating the Role of the ABL Kinase regulated HIF-1a-TAZ Signaling Pathway in the Promotion of Brain Metastasis

ABSTRACT
Brain metastasis leads to cognitive decline and is associated with increased cancer patient morbidity and
mortality. The hypoxic microenvironment of brain metastases, as well as the presence of the blood-brain barrier,
makes these tumors difficult to treat. Current therapies to treat brain metastases are ineffective and lack durable
responses. Therefore, mechanistic understanding of the underpinnings required for brain metastasis promotion
is needed for the development of novel therapeutic strategies. Hypoxia Inducible Factor-1 (HIF-1) is the
master regulator of the hypoxia response and is upregulated in hypoxic areas, including brain metastases. It was
reported that increased HIF-1 signaling correlated with enhanced proliferation of breast cancer metastases in
the brain, and breast cancer brain metastases patient specimens exhibited increased HIF-1 expression
compared to matched primary breast tumors. We have identified a potential functional interaction of HIF-1 with
TAZ, a transcriptional co-activator in the Hippo signaling pathway. Here we propose to evaluate the hypothesis
that this interaction regulates expression of a subset of target genes that promote brain metastasis in triple-
negative breast cancer (TNBC). Notably, we recently found that the Abelson (ABL) family kinases regulate the
expression and activity of HIF-1 in breast cancer cells. We have identified a novel ABL-dependent pathway
whereby an E3-ligase targets HIF-1α for degradation in the presence of ABL kinase inhibitors in hypoxia in TNBC.
Previous work uncovered ABL kinase mediated regulation of TAZ. Thus, we will evaluate whether ABL-
dependent activation of HIF-1 and TAZ in brain metastases leads to enhanced expression of unique
transcriptional targets, and whether inhibition of ABL-mediated HIF-1 and TAZ activation impairs brain
metastases in TNBC. The proposed research is expected to reveal novel mechanistic insights on the modulation
of HIF-1 activity and crosstalk with TAZ downstream of ABL-mediated kinase regulation and elucidate the role
of HIF-1 in the promotion of breast cancer brain metastasis.

Public health relevance
PROJECT NARRATIVE Brain metastasis is an often deadly consequence of triple negative breast cancer, associated with cognitive decline and increased morbidity and mortality. Responses to current therapies to treat brain metastasis are variable, and reoccurrence is common; therefore, novel insights are needed into the mechanisms that promote breast cancer metastasis to the brain. This work proposes to interrogate a novel pathway that promotes brain metastasis and identifies potential treatment options that may be used to prevent and/or treat emerging brain metastases.